Accelerated and programmed mRNA decay by AU-rich binding protein AUF1 in the regulation of muscle regeneration

Project Summary
There is currently significant interest in the potential for skeletal muscle stem cells, known as satellite cells, to
be used in regenerative tissue therapy. The molecular understanding of skeletal muscle stem cell
maintenance, fate determination and differentiation is crucial for translating research to the treatment of
degenerative muscle diseases where there are few effective treatment options. This proposal investigates how
the program of muscle stem cell maintenance, renewal and regeneration are orchestrated by selective,
accelerated mRNA decay directed by the protein AUF1. This is a highly important but largely understudied
area of gene regulation that plays a major role in programming and controlling adult tissue stem cell fate and
tissue regeneration. We build on our previous studies and propose to identify the factors that regulate AUF1
expression in the satellite cell because AUF1 orchestrates the muscle regeneration program of the satellite
cell, identify the satellite cell mRNAs selectively targeted for rapid degradation by AUF1 because this appears
to stage the different developmental events of muscle regeneration, and how AUF1 orchestrates the
progression of reprogramming by interacting with key regulatory proteins because this controls fate
determination of satellite cells from activation to muscle regeneration.

Public health relevance
Project Narrative Regeneration of muscle and its maintenance with aging, disease and wounding is an enormous unmet need. Here we study how targeted mRNA decay by the protein AUF1 orchestrates a program of muscle stem cell renewal and muscle regeneration.